Leveraging Next-Generation Directed Evolution Platforms and Chemical Control of Proteostasis to Deliver Robust Biotechnologies and Illuminate Roles of Chaperone Networks in Protein Evolution

Directed evolution mimics and accelerates natural evolution in the laboratory in order to create useful
new biomolecules and to study evolutionary processes. Although methodologies for directed evolution are well-
established in test tubes and in simple organisms like E. coli and yeast, there is still a major challenge. Specifi-
cally, novel biomolecules derived from directed evolution campaigns in these platforms often fail to function
when transferred to more complex cellular environments, such as that of human cells. To address this critical
issue, our laboratory recently pioneered a directed evolution platform that can be used to repeatedly generate
massive libraries of mutant biomolecules while continuously selecting and enriching the most functional vari-
ants directly in the human cell environment. From a chemical biology perspective, we are also deeply engaged
in studying functions of the proteostasis network – a vital and unique aspect of the human cellular environment
that ensures proteins are correctly folded, processed and trafficked. We have developed an array of chemical
genetic tools to modulate proteostasis, and we are now primed to integrate these tools with our directed evolu-
tion platform to both evolve previously inaccessible biomolecule functions and gain a deeper understanding of
how cells solve protein folding problems.
Altogether, this NIGMS MIRA application seeks to combine two of my laboratory's primary interests: (1)
Developing and applying next-generation, human cell-based directed evolution platforms to generate biomole-
cules optimized for function in complex cells and (2) Integrating evolution with chemical modulation of proteo-
stasis to gain new insights into fundamental principles of proteostasis network function. Here, we propose to
integrate these research areas to deliver an array of biomolecules that reliably and robustly perform valuable
new functions in the complex human cellular milieu. Examples include G-protein coupled receptors controlled
by synthetic regulators for neuroscience applications, systems for incorporation of unnatural amino acids in
proteins, and inhibitors of important signaling pathways related to disease. All of these targets have proven ex-
ceedingly difficult to reliably evolve in lower organisms or test tubes. Beyond these practical advances, we will
also integrate human cell-based directed evolution with proteostasis modulation to gain insights into how the
network solves protein folding problems. For example, we will use our capacity to modulate proteostasis to test
the hypothesis that chaperones can be used to “turbo-charge” directed evolution campaigns by providing ac-
cess to otherwise biophysically unacceptable regions of the mutational landscape. Further, we will pursue an
understanding of the roles of chaperones in human protein evolution, a process that is particularly important in
the setting of tumorigenesis and in the development of drug resistance in oncogenes. Altogether, our contribu-
tions will impact fields ranging from biotechnology and drug development to protein folding biophysics, evolu-
tionary biology, and cancer research.

Public health relevance
Project Narrative Directed evolution is a valuable technique for the development and optimization of proteins with valua- ble new functions, as well as for the elucidation of fundamental biological mechanisms that impact the ability of proteins to robustly explore mutational space. A major issue that currently limits the power of these ap- proaches, however, is that current directed evolution workflows are currently performed almost exclusively in simple systems such as test tubes, yeast, or bacteria. This research will (1) build and apply next-generation, human cell-based directed evolution platforms to open new doors in research and biotechnology and (2) apply evolution strategies in human cells to illuminate how the proteostasis network impacts protein evolution, espe- cially as it relates to diseases like cancer.